Mount Sinai Center for Health and Environment Across the LifeSpan (HEALS)

Project Summary
In the eight years since its inception, the Mount Sinai P30 Center on Health and Environment Across the
LifeSpan (HEALS) has greatly accelerated environmental health science (EHS) research. Using a life course
approach and the underlying philosophy that environment plays an important role in all diseases, we have
formed new transdisciplinary teams partnering with other Mount Sinai P30 Centers in Aging, Cancer, and Skin
Biology, as well as our Clinical and Translational Science Award (CTSA), to bring environment into more
research programs at Mount Sinai. We have prioritized diversity among Center Members, recruits, and trainees
and linked scientists with cross-disciplinary backgrounds to address complex research questions. We
expanded our NIEHS funding base—catapulting from 27th to 2nd in funding dollars—and more than tripled our
overall funding. This growth, largely fueled by our Pilot Projects program, accelerated career development for
our Center Scientists and other Members. The Center supports three Facility Cores: an Integrated Health
Sciences Facility Core that supports biomarker research and access to clinical populations/biospecimens, a
Biostatistics and Data Science Facility Core that supports analysis of environmental data and creates new data
analytical methods needed for exposomic research; and a clinically-oriented Phenotyping and Environmental
Modifier Facility Core that supports state-of-the-art measures of health and environmental modifiers (stress,
nutrition, etc.). Our Community Engagement Core is committed to multi-directional communication and
partners with diverse communities. These partnerships, along with strong links with physicians, enable us to
effectively translate Center research findings into evidence-based approaches for disease prevention and
treatment. In the next funding cycle, the Center will continue to build capacity, new research programs, and
expand further into each of the Core areas. With outstanding institutional support through our Institute for
Exposomics Research and ties to our CTSA, we will bring EHS into all Mount Sinai research programs. In line
with this goal, we anticipate a need for additional human resources and physical infrastructure to increase
Facility Core capacity and to remain at the cutting edge of exposure science and EHS—the Center is essential
to meet these needs. Finally, our program aligns with NIEHS strategic goals: our Research Groups
(Exposomics-Mixtures, Environmental Justice, and Clinical Environmental Research) emphasize the study of
multiple exposures working via multiple mechanisms and move EHS toward health equity research and
precision medicine initiatives. The Center also emphasizes shared biological pathways of exposures, individual
susceptibility, exposomics, environmental causes of disease, and community engagement, all of which are
central to NIEHS's mission. In closing, its remarkable success to date positions the HEALS Center for
expanded reach and impact through continuing to meet the changing infrastructure needs of our environmental
research community to accelerate EHS discovery and translation.

Public health relevance
Project Narrative The Mount Sinai Health and Environment Across the LifeSpan P30 Core Center: (1) supports state-of-the-art research infrastructure to discover the environmental causes of disease and disability across the lifespan, (2) translates scientific discoveries into new, evidence-based strategies for disease prevention and treatment, and (3) builds the careers of young physicians and scientists dedicated to environmental health research.